Axonal TDP-43 Dysregulation in ALS and Dementia

TDP-43 proteinopathy is a hallmark neuropathology among an array of neurodegenerative
disorders, including ALS, FTD, and Alzheimer’s Disease to name a few. Common presentation of
TDP-43 proteinopathy includes the mislocalization of TDP-43 from the nucleus to the cytoplasm,
disrupting its known function as an RNA-binding protein (RBP). This mislocalization alters global
transcriptional dysregulation, such as the increase of cryptic exon expression, as well as effecting
local translation of RNAs. Recent studies suggests that TDP-43 is actively transported into the
axon, mediated by endolysosomal hitch-hiking on kinesin motors, which is perturbed in
neurodegenerative diseases. Moreover, the transport and axonal translation of RNA is important
for neuronal function and axon maintenance. Preliminary data from our lab and existing literature,
suggests that KIF1A might be a candidate kinesin-motor which facilitates the transport of TDP-43
into the axon. Here, we hypothesize that TDP-43 transports RNA to the axon to facilitate local
translation through KIF1A protein, which is perturbed in ALS. The resultant loss of functional TDP-
43 in the axon prevents the localization of key transcripts necessary for de novo protein synthesis
and maintenance of the axon. Downstream consequences of this pathogenic event involve the
perturbance of the axonal proteotranscriptome, loss of proteostasis, and functional deficits that
would otherwise support axon integrity.

Public health relevance
TDP-43 proteinopathy is a common neuropathologic feature of many age-dependent neurodegenerative disorders including, Amyotrophic Lateral Sclerosis (ALS), Frontotemporal Lobar Degeneration (FTLD), and a subset of Alzheimer’s Disease and is characterized by the nuclear clearance and cytoplasmic accumulation of the TDP-43 protein. An RNA binding protein, TDP-43 is found in axons where it is thought to transport RNAs to the distal processes for local protein synthesis, a process critical for maintaining axon health; however, the mechanism through which TDP-43 RNA granules localize to axons, its RNA cargo, and the axonal translation of TDP-43 associated RNAs remains unknown. Here, we propose to characterize the mechanism and binding partners of TDP-43 required for its anterograde transport into the axon (Aim 1); we will also characterize the axonal RNAs and locally synthesized protein due to TDP-43 localization, evaluate if this is perturbed in neurodegenerative diseases axons, and characterize the functional consequence on axon growth (Aim 2).